On-cell screening of mouse hybridomas for improved monoclonal antibody discovery

SUMMARY
OCMS Bio, LLC is seeking to revolutionize monoclonal antibody (mAb) discovery and screening through the
development of an on-cell monoclonal antibody (OCMS) screening platform, an innovative cell-based approach
to substantially improve the hybridoma method for antibody discovery. Monoclonal antibodies have become
essential elements in modern clinical therapeutics, diagnostics, and biomedical research. The hybridoma
approach is one of the oldest and most robust methods for generating mAbs. The vast majority of mAbs for
clinical therapeutics and diagnostics are generated by hybridoma methods. However, this approach is not without
drawbacks, as it is extremely labor intensive and time consuming, because of the need for serial limiting dilutions,
clone propagation, and ELISA screening, which substantially limits the total number of mAbs that can be
screened. To improve this process, OCMS Bio has developed an approach in which mAbs secreted from OCMS
hybridomas are attached to the surface of the cells that secrete them via an innovative anchor-linker system,
which enables rapid screening and characterization of expression with standard imaging workflows. This
eliminates the need for extensive cloning and ELISA-based screening and is expected to decrease the effort
required to screen mAbs by over 80% compared to the traditional hybridoma approach. Furthermore, the OCMS
approach supports the discovery of rare mAbs with ideal specificity and developability parameters, which are
severely limited in traditional hybridoma approaches due to cloning and screening bottlenecks.
OCMS Bio has demonstrated hybridoma formation and the characterization of human mAbs using the OCMS
approach in several human systems. OCMS Bio also demonstrated successful hybridoma formation with mouse
splenocytes. The goal of this research is to develop a method for using the OCMS approach with mouse
splenocytes and rigorously demonstrate 1) reproducible cell fusion for hybridoma formation, 2) stable expression
of the OCMS anchor, and 3) that the OCMS approach substantially reduces the time and effort associated with
mAb discovery, compared to the traditional hybridoma approach. Success with these goals will have substantial
commercial and clinical impact as the OCMS approach will fit within current mAb development workflows and
reduce costs, effort, and development timelines for customers to develop novel lifesaving mAb-based
therapeutics and diagnostics.

Public health relevance
PROJECT NARRATIVE The need for novel monoclonal antibodies (mAbs) is growing rapidly and methods that expedite discovery and reduce costs hold significant potential to impact therapeutic, diagnostics, and biomedical research markets. OCMS Bio is advancing the development of the On-Cell monoclonal antibody Screening (OCMS) platform to reduce the time and costs associated with hybridoma preparation and monoclonal antibody development that will also support the discovery of rare monoclonal antibodies with optimal properties. Success with these goals will reduce development timelines for customers to develop novel lifesaving mAb-based therapeutics and diagnostics.